Virtual Reality Facilitation of Recovery from Opioid Use Disorder

PROGRAM PLAN
Executive Summary of Predicate STTR Phase I Grant and Team
The goals of our predicate STTR Phase I (R41 DA055405) are to demonstrate (i) intervention efficacy, (ii)
effectiveness in the target population, (iii) practicable delivery, (iv) validation of remote deployment in a multi-
site collaboration, and to produce (v) critical non-directive user feedback. These goals emerge from the two
proposed specific aims that target key outcomes in early recovery from opioid use disorder participants
recruited from addiction treatment centers. Demonstrating in-sample effectiveness in the recovery-related
outcomes from Aims 1 and 2 will indicate completion of Phase I and preparation to transition to Phase II.
Converging evidence suggests that psychological disconnection with the future is a central underlying
mechanism in substance use disorder (SUD). Interventions that successfully increase valuation of the future
(i.e., delayed outcomes) present episodic, autobiographical, future-oriented, vivid, and content-specific stimuli.
We developed an immersive virtual reality (VR) intervention that is personalized and hyper-realistic to increase
connection with one’s personal future. This emotionally charged narrative interaction with future selves, (i) after
15 years of substance misuse, and (ii) after 15 years of sustained recovery elicited high rates of abstinence,
increased preference for delayed rewards, increased future-self identification, and decreased craving.
STTR Phase I Specific Aims:
Aim 1: Determine the efficacy of VR future self-experiences on opioid use. The VR Test group, relative to
VR Control, will show (1a) a lower number of opioid use days; (1b) longer abstinence periods during follow-up;
and (1c) significantly increased opioid abstinence rates.
Aim 2: Determine the behavioral effects of VR future self-experiences. The VR Test experience,
compared to baseline and VR Controls, will (2a) increase future self-identification; (2b) increase future
orientation; (2c) increase preference for delayed rewards in a laboratory delay discounting task; and that (2d)
the VR Test group will exceed the VR Control group in the behavioral effects (H2a-c) at the 30-day follow-up.
STTR Phase I randomized controlled trial (NCT05908097) Progress and Preliminary Results:
We modified the paradigm to work on currently available VR equipment, i.e., the Meta Quest 3 (a state-of-the-
art standalone headset), as the original paradigm was designed for the wired Samsung Odyssey headset. We
initiated a multi-site collaboration with an out of state partner, Serenity Lane in Oregon. To-date, we scheduled
n=153 in-person interviews and n=54 study days with participants in early SUD recovery. We collected study
day data from n=37 (n=17 VR Test and n=20 VR Controls), 18 female and 19 male, with a mean age of 41.8
±9.8 years. Preliminary data suggest gains in abstinence and other key metrics for sustained recovery. In
parallel, our team has devoted considerable effort in business development, including conference
presentations, meeting with treatment industry stakeholders, customer surveys, and regulatory consulting.
We overcame several significant challenges during the ongoing Phase I trial. Realistic voice cloning required
testing many hardware and software solutions (including a purpose-built audio recording booth). We eventually
discovered a hardware/software combination well-matched to the python-based AI model (TortoiseTTS).
Participant recruiting was another major hurdle. Numerous in-person recruiting efforts and locally posted
physical flyers fell short of recruiting goals. We overcame this problem with a dual solution: contracting an
online recruiting service, and a participant referral voucher system (IRB-approved). The multi-site collaboration
further expanded our reach for data collection and increased our parallel throughput.
The team comprises Isaiah Branam, Brandon Oberlin, and Andrew Nelson. Mr. Branam’s robust
entrepreneurial experience makes him ideal for business strategy and development. Dr. Oberlin provides the
scientific expertise and testing capacity for the project, and Mr. Nelson’s ongoing industry experience as CEO
of Half Full Nelson, LLC and seven-year collaboration on the project, provide the unique insight and skill set to
continue achieving our aims. While we believe our clear vision will lead us successfully to market, we are
eager to amend that or go back to the drawing board, as needed, based on what we learn at I-Corps. Similarly,
all team members are committed to the time requirements of the program.

Public health relevance
I-Corps Team and Project Plan Our highly novel intervention leverages the power of immersive experience and therapeutic alliance with the self to promote better decision-making and successful addiction recovery. Our published pilot study results suggest that our intervention is capable of increasing both valuation of the future and the psychological connection with the future self (Shen et al., 2022). Emerging findings from the Phase I trial (NCT05908097) are largely consistent with these findings and further demonstrate increased self-efficacy for abstinence. From its inception, the intervention was always intended for wide dissemination by non-technical users with fast turnaround and an intuitive interface. The societal impact of increasing addiction treatment effectiveness is obvious, with 12.8 million people receiving treatment in the past year (SAMHSA, 2024). 1. I-Corps Team Our proposed I-Corps team comprises: Member Role Isaiah Branam C-level Corporate Officer (CEO) Brandon Oberlin, PhD PI, Technical Expert Andrew Nelson Industry Expert Our team’s complementary expertise, ongoing collaboration, and deep commitment to the project make it ideal for the I-Corps program. Dr. Oberlin originally conceived the idea but required technical VR expertise to build the prototype. Mr. Nelson, a digital media developer and small business owner, was recruited as an industry partner to develop the concept into a digital experience. Dr. Oberlin and Mr. Nelson iteratively developed and tested the prototype and published the pilot study results in a respected psychiatry journal (Shen et al., 2022). They also founded Relate XR, LLC, secured STTR funding, filed for patent protection and an option for exclusive license from Indiana University, and continued refining the intervention. Seeking assistance with business development, the co-founders approached Mr. Branam, a highly accomplished young entrepreneur. Mr. Branam and Dr. Oberlin together won first place in the Life Sciences to Healthcare Solutions Pitch Competition (2023; Indiana University Innovation and Commercialization Office; $25k). Dr. Oberlin and Mr. Nelson have been research/industry collaborators since 2018, when they submitted their first grant application together (Indiana University’s Responding to the Addiction Crisis Grand Challenge “Promoting Addiction Recovery with Virtual Reality-Enhanced Prospective Thinking”). Subsequently, Dr. Oberlin’s three NIH-funded VR awards (R01 AA029396, R34 DA055304, and R41 DA055405) were in partnership with Mr. Nelson and his team at Half Full Nelson LLC, as the awards critically relied on his VR development and consulting services. The full team has actively advanced this project together for nearly two years, and the co-founders have been collaborating full-time for nearly seven years. The team has marshaled the concept through prototyping and initial testing to developing validated regulatory and reimbursement strategies. All team members are sharply focused on delivering immersive therapeutics to the public, and are keenly interested in entrepreneurship, public good, and commercialization. All team members are eager to enroll in the I-Corps program and firmly commit to the in-person and online requirements of participation. Team Member Qualifications Mr. Branam, previously one of the youngest venture-backed CEOs in America, built Fia Technologies, Inc. from inception to a seven-figure valuation, earning recognition as ISBDC Startup of the Year (2022). As an Innovation Ambassador to the State of Indiana, he spearheaded international collaborations with automotive legends Ferrari, Lamborghini, Pagani, Ducati, and Dallara, architecting a groundbreaking talent and innovation pipeline between Indiana and Italy's prestigious Motor Valley. His transformative work in technology and economic development has earned him speaking roles at premier innovation conferences including South By Southwest and the Rally Innovation Conference—the world's largest cross-sector innovation conference. Branam now contributes to bringing the 2025 Global Entrepreneurship Congress to Indianapolis, positioning the city to host the most exclusive assembly of global innovation leaders gathered in the American Midwest. Dr. Oberlin’s research career is wholly focused on SUD recovery and addiction mechanisms. His corpus of work is marked by creative and highly innovative solutions. These include the novel deployment of a cross- commodity delay discounting paradigm that used alcohol infusion reward in heavy drinkers (Oberlin et al., 2021), a self-designed and validated MRI-safe sensation seeking task (Oberlin et al., 2020), and most recently a novel VR intervention for SUD early recovery (Shen et al., 2022). The pivot toward high-tech interventions was driven by the large untapped potential of immersive therapeutics. His vision for bringing these products to market is motivated by clinical effectiveness, accessibility, scalability, and public health. Dr. Oberlin’s two decades of research on the neurobehavioral bases of addiction related decision making provide the requisite knowledge to test novel mechanisms of behavior change. Mr. Nelson has spent nearly 25 years working with advanced mixed reality technologies to drive learning, understanding, and behavior change. At Indiana University, he developed immersive experiences in the CAVE (Cave Automated Virtual Environment) lab until 2002. Starting as a digital artist, he eventually led development at Wisdom Tools, focusing on advanced research in Augmented Reality and context-based immersive learning funded by NIH, NSF, and DoD. In 2015, he founded Half Full Nelson, creating immersive works for clients like Harvard, LSU, and the IU Center on Representative Government, as well as multiple AR apps. His work has earned numerous awards, including the Golden Lion at Cannes, a Webby, and the AASL Best App for Teaching and Learning award. The groundbreaking VR experience Dreams of Dali remains in the permanent collection at the Dali Museum. The Half Full Nelson team co-designed and created all past and current versions of the individualized VR paradigms used in Dr. Oberlin's research. Mr. Nelson’s background in fine arts combined with his technical expertise drives improvement of emerging and future iterations. We believe that I-Corps participation will hone our understanding of market needs, inspire solutions to regulatory hurdles, and provide critical networking opportunities. We constantly seek opportunities to learn from potential customers and industry stakeholders, as evidenced by Dr. Oberlin’s presentations and networking at Serenity Lane Alcohol and Drug Treatment Services (8/17/2023) “This is your future: virtual reality recovery support, decision-making, and sensation seeking”, and at the annual conference of the National Association of Addiction Treatment Providers (5/20/2024) “Artificial Intelligence & Virtual Reality: The Future of Technology in Treatment Services”. More recently, the team conducted a fact-finding trip and presented “Enhancing Addiction Recovery” at Caron Treatment Center in Pennsylvania (10/15/2024). Each of these out-of-state ventures produced critical new information from clinicians and decision-makers alike that informed our intervention and implementation strategies. We believe that the I-Corps program will augment our understanding of the market and facilitate connections with industry professionals and regulatory experts. 2. Potential Commercial Impact Commercial Opportunity Our market research reveals a compelling commercial opportunity in the demand for effective evidence-based innovations for SUD treatment. The multi-billion dollar SUD treatment industry is well established in the American healthcare system and is supported by a mature regulatory and reimbursement ecosystem. The market opportunity is immense: 46.3 million Americans (1 in 6) meet DSM-5 criteria for substance use disorders (SAMHSA, 2021), with 12.8 million receiving substance use treatment in the past year (SAMHSA, 2024). The need for revolutionary approaches is crucial, with conventional treatments resulting in up to 90% relapse rates, even with medication assistance (Weiss et al., 2011). Through extensive customer discovery, including interviews with 21+ treatment centers, we have validated strong interest in adopting novel VR solutions. Our path to market leverages proven channels. Under the guidance of Dr. Michael Drues, a globally recognized FDA consultant with 30+ years of experience advising both FDA and Health Canada, we are pursuing FDA 510(k) clearance through validated predicate devices. Following AppliedVR's HCPCS-E1905 reimbursement precedent as durable medical equipment, we are advancing promising discussions with major payers including BCBS, Optum, and Elevance—including their strategic VC arms. This uniquely positions us to disrupt a market desperate for innovation while delivering meaningful commercial and societal impact. Typical Customers Our solution serves three key stakeholders—treatment centers, insurers, and patients—each with distinct needs and decision drivers. SUD treatment centers prioritize evidence-based interventions to reduce relapse rates and improve post-discharge outcomes. These facilities value clinical efficacy and operational efficiency, with key decision drivers being improved outcomes, seamless integration, and clear reimbursement channels. Our customer interviews reveal that ideal solutions dramatically improve efficacy without additional staff burden. SUD treatment facilities are eager to offer greater value to clients while reducing staff workload. Insurance payers, including private insurers and government payers, seek solutions that demonstrate clear economic benefits and fit existing reimbursement models. Conversations with our industry consulting partners suggest that preventing a single relapse saves insurance networks $50,000-60,000, creating a compelling economic case. Payers require empirical outcomes data to provide coverage—critically, most patients cannot access new treatments without insurance reimbursement. Our patient profile focuses on adults (18-65) who have completed or are currently enrolled in SUD treatment and need support during their critical first year of recovery. These patients typically have insurance coverage (accessing Medicaid or state programs as needed) and are motivated to maintain sobriety. This patient population demands discretion and identity protection, due to the stigma surrounding SUD and recovery. The privacy and convenience of at-home use and insurance coverage are key decision drivers for this group. Customer Needs and Available Alternatives Although our target patients have already made an initial commitment to recovery, the struggle to visualize long-term recovery benefits remains an ongoing challenge. Accessible, engaging solutions that differ from traditional therapy are appealing, as many patients have previously tried—and failed—with conventional methods. To help patients visualize recovery benefits, clinicians currently rely on basic tools like verbally- directed visualization exercises and traditional printed materials. Recovery support typically depends on manual processes like periodic check-in calls, support group meetings, and self-reported sobriety tracking. Critically, current solutions fail to address the fundamental challenge: helping patients remain focused on the value of distant recovery rewards. A lack of focus on future recovery benefits quickly leads to the alternative and much-practiced return to drug use. The failure to deliver potent messaging and sharp focus on recovery rewards leads to high relapse rates and poor long-term outcomes. The only currently available digital solutions for this market are cue exposure paradigms, meditation-related applications, and CBT-style emotion regulation training. We integrate hyper-realistic 3D interactive ‘deepfake’ technology with proven behavior change methods to create a powerful, lasting, therapeutic experience unlike anything else previously developed. Competitive Advantage Our value proposition is better recovery outcomes: reduced drug use, and improved decision making. Relate XR offers distinct competitive advantages for both treatment centers and their patients. Centers can seamlessly integrate our solution into existing protocols while dramatically improving patient care. Patients receive insurance-covered access to innovative treatment, eliminating the financial barriers that typically prevent adoption of new therapeutic approaches. Following any inpatient engagement, the convenience and privacy of 15-minute weekly sessions from home supports consistent engagement throughout the critical first year of recovery. This alignment of clinical and patient benefits creates a sustainable model where providers can efficiently help patients maintain long-term recovery at little to no cost to the patient. The moat protecting our intellectual property is the provisional patent (18/030,936; “Avatar-based Behavior Changing System and Method”), our substantial in-house clinical database dating to 2018 (requiring significant time and resources to replicate), and the institutional knowledge from the n=98 tested in the prototype, pilot, and three current trials (and the Oregon multi-site). Our efforts with FDA 510k clearance and unique insights into the new HCPCS code E1905 for reimbursement position us for market capture well ahead of competitors. Even sophisticated latecomers will be forced to navigate a steep learning curve to get them to where we are at this moment. Pricing Model Our patients will receive an immersive personalized therapeutic experience that is enjoyable to use, enhances their recovery goals, and offers value throughout their first (critical) year of recovery. Our solution will be classified as durable medical equipment under HCPCS-E1905, following AppliedVR's precedent with RelieVRx. Similar to renting mobility equipment post-surgery, we'll rent headsets to patients. CMS determined a preliminary payment rate for RelieVRx of $204.66/month (Months 1-3) and $153.50/month (Months 4-13). By crosswalking this CMS valuation for our 12-month Relate XR program, we arrive at a $1,995 CMS valuation. This valuation positions us well below current treatments (e.g., Vivitrol; $1,700/month). Establishing insurance coverage eliminates out-of-pocket expenses for patients, thus removing the primary barrier for adopting new interventions. Our approach follows AppliedVR's validated reimbursement pathway while delivering compelling value to all stakeholders. 3. Project Plan We completed the prototyping phase with funding from an Indiana University CTSI award (PRMC UL1TR001108, “Enhancing Prospective Thinking in Early Recovery”), and conducted an open-label trial with participants recruited from local treatment centers. We obtained NIDA STTR funding to conduct a randomized controlled trial (R41 DA055405, NCT05908097) of the minimum viable product—currently ongoing. We sought IP protection in a multi-national patent application (ID: 63172814, pending 18/030,936) and signed an option for exclusive license with Indiana University. In parallel with the STTR Phase I trial, Dr. Oberlin’s laboratory is conducting two additional trials in closely related populations (NCT05835921, NCT06302413) using essentially the same intervention. Together, these findings will demonstrate generalizability of the intervention to SUD more broadly, rather than use disorders related to particular substances. Expanding the efficacy claim to polysubstance use (plus alcohol) will be essential to capture significant clinical interest and market share. Technology and Procedure Our novel VR intervention, dubbed “experiential psychotherapy” or “VR self- counseling”, can be delivered nearly anywhere, provided the environment lacks excessive noise and distraction. The application of the method beyond SUD is obvious, potentially extending to any type of behavior change. The essence of the “Future Reality Portal” intervention is an immersive simulation with future selves (Fig 1) in Immersive VR Experience: Future Reality Portal Scene 1, White Room; Body Transfer/Identification: The participant looks into a virtual mirror to observe precise avatar mimicry, reinforcing avatar connectedness through ‘body transfer’. The Present Self then emerges from the mirror, invokes personal identifiers, and invites the participant to sit down on a park bench (which is also physical). The Present Self produces two large crystal balls and urges the participant to “choose a future” and time travel 15 years into the future to the year 2039 (decision point). The scene then transports to the park, with the participant seated ~1 meter from their Future Self avatar. This scene connects the participant to the avatar and reinforces the connection between a decision point and future outcomes. Scene 2, Park Scene; SUD Future: The SUD Future Self (slouched on a park bench, unkempt and distressed-looking) discusses how life’s important things were lost to opioid use, and that 2024 was a missed opportunity for recovery. The scene ends with the SUD Future Self saying, “Don’t let this happen to us.” Scene 3, Park Scene; Recovery Future: The Recovery Future Self (poised on the bench, appearing neat, healthy, and positive) describes a fulfilling alcohol/drug-free journey and realization of dreams. [Note: “important things” and “dreams” from both futures are personalized from interview answers]. The Recovery Future Self thanks the participant for their hard work and offers encouragement. The scene ends after the Recovery Future Self smiles and says, “You can do this”. Scene 4, White Room; Wrap-up: The Present Self encourages the participant, affirms agency, and reinforces the continuity between present action and future outcomes. plausible personalized futures. The inset panel summarizes the interaction, delivered by an animated, hyper- realistic age-progressed avatar in the participants’ own voice. The current workflow and delivery system in the clinical trials comprises a brief interview (including several photos and a voice sample), upload to our server, offsite paradigm creation, and download to the headset (Fig 2). Participants then experience the Future Reality Portal. This minimal viable product, which is currently fully functional, forms the template for future iterations and enhancements. Preliminary Phase I Results The VR Test group showed 13% gain in abstinence rates relative to VR Controls, (85% versus 75%, respectively); a median increase of 1.0 in both future self-similarity and connectedness in VR Test and zero change in Controls (non-significant); significant gain in delayed reward preference in VR Test (p=.020), and a 36% decrease in predicted “likelihood of relapse in 1 year” in VR Test (p=.041), but no change in Controls (p=.083). Overall results are highly promising although requiring additional power to detect some group differences. Future Directions (Phase II) The current workflow and delivery system in the clinical trials are managed by technical staff, however, we are developing a user-friendly frontend, cloud hosting, and AI-based automated workflow so that the product can be easily used by non-technical customers. One of Dr. Oberlin’s research projects (R01 AA029396) utilizes an elaborated version of the paradigm with a take-home headset pre-loaded with 30 daily experiences to continuously renew the connection with the future self. Participants report good useability and high engagement, even without supervision. Based on feedback from stakeholders in the treatment industry, we intend to expand this into 52 weekly experiences infused with clinician-informed cognitive behavioral therapy elements. We envision the product as a “get started” package that Fig 1. Following Scene 1 (see inset), participants are transported to the park bench and interact with their contains simple instructions, a headset, and a link. The future selves, shown here as their (A) SUD Future Self, customer will use a smartphone to go to the link, which will and (B) Recovery Future Self. guide them through uploading photos, a voice sample, and providing a few personal details. They will then turn on the headset, ensure internet connectivity, and download the bespoke experience. Their Present Self will then guide them through the experience inside VR. This will provide an encouraging ‘recovery co-pilot’ to marshal them through the challenges and joys of a successful early recovery. During and after the I-Corps Fig 2. The current workflow and delivery. Future iterations will utilize AI tools to automate much of it, program, we will continue to decreasing delivery time and cost, and increasing accessibility. The market product is intended to be develop the pathway to FDA provided to and used by non-technical clinical staff or individual customers. 510k clearance and insurance reimbursement. Alongside these efforts, we will test our improved system in a larger clinical trial, using what we learned in the Phase I, and engaging multiple partners for multi-site data collection. This will facilitate high throughput and increase generalizability through nationwide sampling. We believe that the I-Corps program will challenge our assumptions, refine our understanding of the market, increase our regulatory sophistication, and connect us with key players in the mental healthcare industry. We also believe that the I-Corps experience will position us as more competitive Phase II applicants, and ultimately market success.